Basic Medical Research Training in Oncology

PROJECT SUMMARY
The objective of the University of Chicago training program in Basic Medical Oncology is to provide an
outstanding interdisciplinary research training environment for postdoctoral fellows who have completed
internal medicine residency training in order to prepare them for research-intensive careers in academia,
government, industry and community based practices. Candidates for T32 training are recruited from the
ACGME-accredited hematology/oncology training in the Section of Hematology/Oncology within our
Department of Medicine with the expectation that candidates for T32 training will complete one clinical year
funded by the hospital and then have a minimum of two or three years of research training under the
proposed training grant depending on whether they perform patient-oriented research or fundamental
basic/translational/population research. The direction of the program – provision of multidisciplinary, structured,
career development, advising and learning opportunities in cancer research – has not changed since the
program's inception, but we have continued to evolve the program in response to a national need to develop
and/or enhance research training opportunities for individuals from diverse backgrounds interested in team
science and translational research. There are several unique structural elements in the research training
proposed: 1) access to a diverse population of cancer patients; 2) training under the guidance of
multidiciplinary research preceptor(s) within a robust scientific environment that provides innovative scientific
approaches, tools and technologies; 3) specific educational pathways in the form of course work and special
seminars leading to a Masters degree from any relevant unit in the University; and 4) service learning
opportunities to improve health equity in our catchment area on the Southside of Chicago and across the
globe. The 33 Senior and 22 Clinical/Junior research training faculty preceptors have NIH or equivalent peer-
reviewed funding, interact on a number of collaborative research and training efforts and are well qualified to
serve as potential mentors for the six trainees per year participating in this T32 program. In the proposed grant
period, we shall continue the successful elements of the program in Clinical Pharmacology, Genomics and
Immunotherapy. At the same time, we shall enhance the curricular offerings by providing coursework in
emerging areas of cancer research including Epigenetics, Metabolomics, Medical Informatics, Quality of Care,
Implementation Science and Global Cancer Research. Our extensive inpatient and outpatient facilities promote
a comprehensive clinical training experience, while our research laboratories allow for the acquisition of basic
research skills. In addition, our diverse populations on the Southside of Chicago and our global partners will
provide learning opportunities in community engaged research locally and at International sites to advance
novel interventions to reduce the global burden of cancer. With the rapid pace of scientific advancement, a well
trained oncology work force as proposed in this training program remains a wise investment for the nation.

Public health relevance
PROJECT NARRATIVE The objective of the training program in Basic Medical Oncology at the University of Chicago is to provide an outstanding interdisciplinary research training environment for clinician postdoctoral fellows who have completed internal medicine residency training. Physicians completing our training program will enter the oncology work force as socially responsible citizens who are prepared to lead cancer-focused research teams in academia, government, industry or community settings.